Sex Differences in the Neural Control of Social Behavior; Supplement

PROJECT SUMMARY
This project aims to understand the function of sex differences in neural control of social behavior by
focusing on the higher level of vasopressin expression in male versus female brains. This is the most
consistently found sex difference among vertebrates, and the best understood in terms of function in
adult animals. This grant will study whether the sex difference in vasopressin innervation contributes to
sex differences in the display and control of social behavior. We will take advantage of new powerful
genetic approaches that allows us to target vasopressin cells specifically. The first aim is to test whether
concurrent removal of the sexually dimorphic vasopressin cells in the bed nucleus of the stria terminalis
and medial amygdaloid nucleus affects social behavior differently in males and females. The second aim
is to test whether inhibition or excitation of these cells alters social behavior differently in males and
females. The third aim is to identify the in- and outputs of these cells, to begin to understand the neural
circuitry via which vasopressin affects social behavior differently in males and females. Understanding
how the brain controls social behavior differently in males and females as many behavioral disorders
show striking sex differences in morbidity. Sexual differentiation of the brain likely contributes to these
differences. Although recently major advances have been made in understanding the neural basis of
social behavior in adulthood, how such behavior is controlled differently in males and females is, by and
large, unknown. This grant will address these issues.

Public health relevance
PROJECT NARRATIVE Behavioral disorders that have a strong social component, such as autism spectrum disorders, are often more common and severe in males than in females. Sexual differentiation of the brain likely contributes to these differences. This research explores the behavioral consequences of sex differences in neural systems implicated in social behavior.